Role of NK cell subsets in an animal model of relapsing-remittingmultiple sclerosis

PROJECT SUMMARY/ABSTRACT
The goal of our lab is to investigate immune regulation for the treatment and resolution/repair of central nervous
system (CNS) inflammatory diseases. During neuroinflammation the concerted actions of the CNS and the
immune system affect the pathological responses mediated by infiltrating and resident immune cells. In
particular, during multiple sclerosis (MS), myeloid and lymphoid cells are found in abundance in the CNS. While
anti-CD20 treatment opened the mind of scientists in targeting non-T cells in MS, other immune cells remain
severely understudied for their contribution in MS pathology. Recently, innate cells have gained a lot attention in
MS, and in particular the natural killer (NK) cells. NK cells are known for their anti-viral/tumor activity, as well as
their regulation of adaptive immunity. NK cells are typically divided into immature NK cells (iNK), denoted as
CD56bright and mature NK cells (mNK), denoted as CD56dim. In MS, the role of NK cells is inconclusive. NK cells
are found in high number in the cerebrospinal fluid (CSF) of MS patients, and depletion of NK cells at peak of
disease in the animal model of MS, experimental autoimmune encephalomyelitis (EAE), leads to attenuated
disease severity. These data suggest that NK cells are contributing of MS pathology. However, other studies
have shown potential beneficial roles of NK cells in MS. Indeed, deletion of NK cells before EAE disease
induction leads to a worsen of disease. Moreover, MS patients treated with Daclizumab (IL-2Rα blocker) showed
a decrease of brain lesions which correlated with an increase of CD56bright iNK in blood. Together, these data
suggest that different NK subsets might play different roles in MS. However, an important hurdle to study NK cell
subsets in EAE is the absence of CD56 in mice. Recently, multiple groups were able to overcome this handicap,
and identify markers to distinguish mNKs (NKp46+ CD49b+ CD27- CD11b+) from iNKs (NKp46+ CD49b+ CD27+
CD11b-). Preliminary, we are showing that both subsets exist in the spleen and CNS in the relapsing-remitting
model of EAE (RR-EAE). We are also showing robust expression of GM-CSF and IL-17 by mNK in the CNS of
EAE mice, while iNKs are showing minimal expression of both cytokines. Based on published data as well as
our preliminary data, we hypothesized that the mNK subset contributes to EAE pathogenesis while the
iNK subset ameliorates it. In our first aim, we plan to characterize NK cell subpopulations in the CNS of RR-
EAE mice at different stages of the disease using single cell RNA sequencing. Using publicly available human
MS scRNAseq datasets on blood, CSF and RRMS lesions, we plan to overlay our murine scRNAseq to evaluate
if NK subsets found in EAE are also present in MS. In the second aim of our study, we will evaluate the functions
of iNKs and mNKs in the CNS by using an in vitro co-culture assay between CNS slice culture and NK subsets,
as well as carrying out in vivo experiments by transferring CFSE-labelled NK subsets into EAE mice. We believe
that understanding which NK subsets are present at different points of disease, along with whether these cells
are regulatory or pathogenic, will gain more insight on potential targets that could benefit future therapeutics.

Public health relevance
Project narrative Multiple sclerosis (MS) is an autoimmune disease in which immune cells enter the brain and attack the self- protein myelin, critical for the functions of neurons. The role of natural killer (NK) cells in MS is unclear, with some studies showing a protective role, while others show that these cells contribute to the disease pathology. Using an animal model of MS, this project aims to determine if there are multiple subsets of NK cells infiltrating the brain during disease, the disease stage in which these cells come into the brain and their respective roles in the brain during disease.